Studying Atherosclerosis Macrophage Dynamics by Combined PET and Fluorine-MRI

PROJECT SUMMARY
Atherosclerotic cardiovascular disease (CVD) is the main cause of morbidity and mortality worldwide.
Thrombotic complications in atherosclerosis often lead to severe clinical events (myocardial infarction and
stroke) and are mostly the consequence of active chronic vessel wall inflammation, characterized by presence
of abundant plaque macrophages. Immunological studies have elucidated that macrophage dynamics in
atherosclerosis is a complex systemic process which, after initial production of monocytes in the bone marrow,
involves (i) monocyte egress (E) from the bone marrow and spleen, and subsequent plaque (ii) monocyte
recruitment (R), resulting in increased (iii) macrophage accumulation (A). Although many different aspects of
macrophage dynamics in ischemic heart disease have been elucidated, our current knowledge of the complex
systemic interactions between immune organs and the vessel wall is exclusively based on snapshot
immunological assays. In the absence of suitable in vivo readouts, an all-encompassing view on these different
processes is difficult to acquire. The goal of our application is to develop an integrated multimodality imaging
platform based on fluorine (19F) magnetic resonance imaging (MRI) and nanobody positron emission
tomography (PET) that allows studying all aspects of macrophage dynamics in atherosclerosis, through the
use of monocyte/macrophage-specific MRI and PET probes. We will employ these techniques to quantitatively
map macrophage dynamics in atherosclerotic mice during disease progression and after novel
nanoimmunotherapeutic intervention. 19F-MRI will be used to track monocyte egress (E) from the spleen, a
process that happens gradually (during atherosclerosis progression) (Aim 1A). Monocyte recruitment (R) to
and macrophage accumulation (A) in atherosclerotic plaques will be instead quantified using PET imaging of
radiolabeled nanobodies (antibody fragments with ideal pharmacokinetics for vessel wall imaging) targeted
against vascular cell adhesion molecule 1 (VCAM1) (R) and macrophage mannose receptor (MMR) (A) (Aim
1B). Combined 19F-MRI and nanobody PET will be used to map macrophage dynamics during atherosclerosis
progression (Aim 1C), and treatment with a novel nanoimmunotherapy based on TRAF6 inhibition - which we
show to specifically impair monocyte migration - to either slow down atherosclerosis progression (Aim 2A) or
induce atherosclerosis regression (Aim 2B). We foresee that our findings will set the foundation for future
studies of macrophage dynamics and targeted immunotherapies in the context of plaque thrombosis and
cardiovascular events, for an improved stratification of cardiovascular risk.

Public health relevance
NARRATIVE Seminal preclinical work and studies in patients indicate that atherosclerosis progression and the onset of cardiovascular events, such as myocardial infarction and stroke, are mediated by the complex trafficking of immune cells between the arterial vessel wall and hematopoietic organs. To improve our understanding of these complex processes, we propose to use a combination of fluorine magnetic resonance imaging (MRI) and positron emission tomography (PET) to collectively map atherosclerosis macrophage dynamics in vivo and non-invasively. In the future these techniques may be translated to study the immunological impact of cardiovascular disease triggers such as stroke and myocardial infarction, and for a more comprehensive assessment of cardiovascular risk profile.